The Warburg Effect and Diabetic Retinopathy

Project Summary/Abstract
Retinal neovascularization (RNV) is a debilitating complication of advanced diabetic retinopathy, which despite
the use of anti-VEGF and laser treatments continues to cause blindness. Less is known as to why RNV develops
only after patients have had diabetes for decades. Although endothelial cell (EC) angiogenic activation is a
hallmark of this transition, how ECs adapt their metabolism to sustain such activation remains a significant gap
in our knowledge. Our long-term goal is to determine the bioenergetic mechanisms of RNV. The Warburg effect
is a metabolic shift from mitochondrial oxidative phosphorylation (OxPhos) to hyperglycolysis that was first found
in cancer cells. This metabolic shift not only produces ATP faster than OxPhos, albeit less efficiently, but also
provides precursors required for lipid, protein, and nucleotide synthesis during cell proliferation. Recently the
Warburg effect was rediscovered as a key contributor in various endothelial-related diseases; however, its role
in diabetic retinopathy is not well-defined. In this application, the overall objective(s) are to define the role of
the Warburg effect in diabetic retinopathy and to identify its underlying mechanisms. Here, we propose that
multiple hits are needed to cooperatively alter EC metabolism to fulfill biosynthetic demands of transforming a
quiescent EC into an angiogenic cell. Tissue hypoxia is the most common risk factor associated with advanced
diabetic retinopathy. Thus, our central hypothesis is that diabetes primes quiescent ECs to be angiogenic (first
hit) and that hypoxia (second hit) is necessary for angiogenic switch via the metabolic adaptation of the Warburg
effect. Aim1 will test the hypothesis that persistent activation of the energy sensor, AMP-activated protein kinase
(AMPK) sustains the Warburg effect to mediate EC angiogenic activation. Our approach is to use a two-hit model
of diabetes and hypoxia in AMPKα1 endothelial-specific conditional knockout (AMPKα1End-/-) mice and in AMPKα1
silenced human retinal ECs (HRECs) to achieve this aim. We will also use vitreous samples from patients with
proliferative diabetic retinopathy to test the correlation between the development of RNV and the Warburg effect-
associated metabolites. Aim2 will investigate the role of endoplasmic reticulum (ER) stress in mediating the
Warburg effect-induced EC angiogenic activation. We hypothesize that activation of Inositol-requiring enzyme
(IRE)1, a unique ER-stress sensor protein with kinase and RNase activities, is a key mediator for the Warburg
effect-induced EC angiogenic activation. We will use CRISPR/Cas9 to test the effect of inhibiting downstream
signaling of IRE1 kinase and RNase activities on the Warburg effect-induced EC angiogenic activation. We will
also test our hypothesis in vivo using a two-hit model of hypoxia and diabetes and selective pharmacological
inhibitors. Overall, this new-investigator initiated R01 capitalizes on the interdisciplinary expertise of a
biochemist, a mitochondrial biologist, an ER biologist, and a clinician to use a novel two-hit model of advanced
diabetic retinopathy to gain mechanistic insights into the bioenergetic basis of RNV. Understanding the role of
the Warburg effect will reveal novel targets in the treatment of diabetic retinopathy.

Public health relevance
Project Narrative Patients around the world underscore the fear, challenges, and toll accompanying diabetic retinopathy, a major progressive blinding disease. The proposed studies will advance our knowledge in explaining how diabetic retinopathy progresses to a later stage of neovascularization through the metabolic adaptation of the Warburg effect. Aligned with the mission of the National Eye Institute to prevent diabetes-related blindness, this project holds great promise in providing a new strategy, through the use of inhibitors of the Warburg effect, for preventing and/or treating diabetic retinopathy.